Wnt/Frizzled-PCP signaling in development and disease

Epithelial cells are polarized in two axes for their function, ubiquitous apical-basal polarity and a second axis
within the epithelial plane, called Planar Cell Polarity (PCP). Cell polarity and associated ordered cellular
arrangements and patterning during organogenesis and homeostasis depend on Wnt-signaling mediated PCP
mechanisms. Classical examples of PCP organized tissues include in Drosophila adult cuticular structures, like
the wing and thorax epithelia, and in mammals striking aspects of PCP are evident in the skin, the inner ear
epithelium, or the respiratory system and most other internal organs. Moreover, convergent extension
processes during gastrulation and neural tube closure require Wnt/PCP signaling. Similarly, the PCP pathway
is linked to the regulation of asymmetric cell divisions in stem cells of many organs. Studies of PCP
establishment in Drosophila continue to serve as a paradigm to unravel this type of polarity in development and
human disease. PCP is coordinated by Wnt ligand signals, resulting in asymmetric localization of their
receptors, the Frizzled (Fz) proteins, and associated signaling cascade. Core Wnt-Fz/PCP factors are required
to interpret polarity within the cell and relay this to neighboring cells. All core PCP members are evolutionarily
conserved and regulate all PCP aspects studied. This Wnt-pathway is distinct from canonical Wnt-Fz/β-catenin
signaling (and correct regulation of signaling specificity between the two Wnt-pathways, activated by the same
receptor(s), is critical for development and disease). The cellular mechanism(s) affecting polarity downstream
of either Fz or Vang (Vangl1/2 in mammals), with Vang/Vangl being the intercellular transmembrane PCP-
partners of Fz proteins, remain poorly understood. The focus of my lab’s research, and this application, is to (i)
continue to investigate the mechanistic interactions of the core PCP signaling factors and the resulting cellular
read-outs and intracellular responses, (ii) to establish connections between the core Fz/PCP pathway and the
Fat/Ds-PCP cassette, and (iii) – a recent addition to our efforts - to dissect the non-ciliary function(s) of ciliary
proteins in both, canonical Wnt/β-catenin signaling and Wnt/PCP pathways, with the advantage of being able
to do so in non-ciliated Drosophila cells. This recent focus originates from genetic screens, identifying such
non-ciliary functions of cilia associated factors. Exciting ongoing experiments are addressing the physiological
significance of regulatory interactions between the Fz- and Vang-complexes, and how these affect either Fz or
Vang cytoplasmic effectors and their cell biological responses to PCP signaling, including effects on cell
adhesion and tissue fluidity, or its impact on cytoskeletal regulation. Another major focus is based on our
identification of the Kinesin-2/IFT-A complex being required for the nuclear translocation of β-catenin. We are
continuing our mechanistic dissection of this exciting and unexpected microtubule associated process.
Information acquired here will advance our fundamental understanding of cellular polarization and the role of
ciliary proteins in either Wnt-signaling pathway, and also provide insight into Wnt-signaling disease contexts.

Public health relevance
Cellular polarity is an essential feature of organogenesis and tissue development and homeostasis in general. The regulation and maintenance of the epithelial planar cell polarity (PCP) feature is linked to many diseases, ranging from deafness and infertility to neural tube closure defects and ciliopathies, and also cancer (several PCP determinants are tumor suppressors or proto-oncogenes). This application addresses the cell biology and molecular regulation of PCP establishment, which is of high significance for many medical disorders.